Training the Next Generation of Chemical Biologists

Project Summary
This exciting pre-doctoral training program at the Chemistry-Biology Interface involves 30 training faculty
from three departments at the University of Minnesota including Chemistry, Medicinal Chemistry, and
Biochemistry, Molecular Biology and Biophysics (BMBB). The mission of the program is to provide a diverse
cadre of students with the skills necessary to cross traditional boundaries, think critically and understand and
conduct rigorous scientific research at the interface of chemistry and biology. This mission will be accomplished
by achieving the seven specific objectives listed below. Over time, it is expected that trainees will progress in
their development as professional scientists in the areas of career awareness, knowledge of chemical biology,
professional scientist development, and rigor and reproducibility. Success in achieving those goals will be
evaluated through the use of quantitative metrics. This mission will be accomplished by achieving the following
objectives:
(i) Provide students with an interdisciplinary training experience at the interface of chemistry and biology. This will
be accomplished by a combination of coursework involving classes from three different departments and by a
cross-training experience involving a coadvisor and a research experience of at least three months in the
coadvisors laboratory.
(ii) Promote rigor and reproducibility in research through a combination of an online introduction, classroom
instruction and interactive workshops.
(iii) Expose students to cutting-edge science at the interface of chemistry and biology through seminars focused
on this type of interfacial science (Chemical Biology Colloquium, CBC) and by allowing them to organize their
own symposium focused on the chemical biology interface.
(iv) Enhance the communication skills of trainees by providing them with multiple opportunities to present their
research in different formats including a presentation at a national or international conference.
(v) Educate students about the range of career opportunities available for scientists with training in this area.
(vi) Stimulate interest in the training program by involving students, faculty and industrial scientists from local high
schools, four-year colleges and companies in training activities.
(vii) Increase the diversity of scientists carrying out research at the chemistry and biology interface in our
program through a combination of different outreach activities.
Research carried out in connection with the program will span a wide range of topics ranging from the
development of fundamental chemical technologies to discover new biology, to the study and treatment of
diseases including cancer, aging and infectious disease. The training faculty members are a highly collaborative
group with a rich history of joint publications among the mentors and are committed to devoting the time and
effort it takes to effectively mentor students.

Public health relevance
Project Narrative This exciting training program seeks to prepare students to perform research at the interface of chemistry and biology. It includes rigorous scientific training coupled with additional activities designed to improve the success of young scientists in launching their own careers. Research carried out in connection with the grant spans a wide range of topics ranging from the development of fundamental technologies to discover new biology to the study and treatment of diseases including cancer, aging and infectious disease.